Cellular heterogeneity and niche regulation in TMJ

PROJECT SUMMARY
Temporomandibular joint osteoarthritis (TMJ-OA) is a degenerative joint disease of the jaw and a major driver of
temporomandibular disorders (TMDs) that affects approximately 11 million individuals in the United States alone.
TMDs are commonly characterized by severe pain and functional defects that lead to TMJ dysfunction and
negatively affect the quality-of-life in patients. However, the developmental and pathophysiological mechanisms
in TMJ development and disease are poorly understood, thus creating significant barriers to identifying novel
non-invasive treatments for TMDs. Here, we aim to examine the cell lineage heterogeneity and molecular
mechanisms that contribute to TMJ development and assess how TMJ cell subpopulations are dysregulated in
disease. We hypothesize that the fibrous surface layers of the mandibular condyle are composed of unique
progenitor cell populations that regulate TMJ development and may contribute to TMJ-OA pathophysiology.
Further, we will examine how alterations in the structural organization of the progenitor niche can impact cell
lineage plasticity. In Aim 1, we will use single-cell transcriptomic analysis, lineage tracing, and TMJ-OA preclinical
modeling to define unique cell subpopulations in the TMJ and their role in TMJ-OA pathogenesis. In Aim 2, we
will determine how impaired organization of the fibrous superficial layers of the mandibular condyle alters TMJ
progenitor cell differentiation using single-cell multi-omics approaches and investigate the underlying molecular
mechanisms that cause TMJ dysfunction.

Public health relevance
PROJECT NARRATIVE We aim to leverage state-of-the-art multi-omics approaches to characterize the wide range of unique cell populations that reside in the TMJ. We anticipate that our findings will shed light on the molecular and cellular mechanisms of cell lineage plasticity during TMJ development and disease, as well as the regulatory role of the progenitor microenvironment. Together, the proposed studies will contribute to foundational knowledge which may provide the basis for developing mechanism-based therapies to deter pathological progression in TMJ-OA.